MULTICENTER TRIAL OF THERAPEUTIC OXYGEN FOR PRETHRESHOLD RETINOPATHY

Determines if moderate elevation of inspired oxygen in premature infants with prethreshold of reinopathy (ROP) will decrease the risk of progression of the disease, thereby decreasing the risk of blindness from ROP induced retinal detachment.